Improving transplantation access, equity and outcomes through responsive risk communication and support for living donor candidates with obesity.

PROJECT SUMMARY
Kidney transplantation is an area of scarcity with demand for transplantable kidneys for those on the waiting list
continuing to outstrip supply. Increasing living donation rates, where someone donates one kidney while alive
to someone whose own kidneys don’t function, is the most promising way to increase the number of kidneys
available for transplant. Growing obesity rates, however, threaten to curb this supply, as having a high body
mass index (BMI) may rule out a potential living donor from evaluation. There is considerable disagreement
about the use of BMI as a determinant of eligibility with practices varying across and between countries and
transplant centers. Some say that risks can be modified or are justified. Reducing risks to potential living
donors would entail engagement with weight loss interventions. Access to and success of weight loss
interventions are highly variable.
Given these complexities and the need to increase the supply of organs, key ethical questions around risk,
fairness, and equity need to be examined and addressed for the involvement and protection of obese living
donors. It is vital to establish appropriate health screening measures and accurate and effective risk
communication for obese living donors. Understanding whether weight loss is desirable, accessible, or
achievable for those wishing to donate is important to providing responsive support. Discussions of what we
owe those taking the significant steps of both losing weight and donating an organ at personal risk to help
another are critically needed.
By first understanding current practice (Aim 1) and how excluded donors feel about risk and justice issues
related to weight loss and living donation (Aim 2), we will combine empirical findings, clinical evidence, and
normative analysis to generate expert recommendations for the decision-making and equitable support of
obese potential living donors (Aim 3).This project will build bioethics capacity by producing empirically informed
recommendations and drafting tools that support equitable practice in living donation, an area of scarcity with
great clinical and ethical complexity.

Public health relevance
PROJECT NARRATIVE Living kidney donation, where someone donates one kidney while alive to someone whose own kidneys don’t function, provides the best outcomes for kidney patients needing renal replacement therapy. The growing prevalence of obesity in society reduces the numbers of potential living donors, since motivated individuals who have a high body mass index (BMI) are eliminated from being medically screened as donors and are not offered any support to help them lose weight. There is an urgent need to address issues of fairness in screening, comprehension of risks and benefits for both potential donors and recipients if a potential donor lost weight, and, if indicated, access to weight loss education and support programs. By interviewing excluded obese potential living donors about their views, experiences, and education and weight loss needs, this project will produce empirically informed recommendations and draft tools that support ethical and equitable decisions about living donation in situations when potential donors are obese.